Early Detection and Diagnosis of Lung Cancer with Endomicroscopy

PROJECT SUMMARY
Early diagnosis of lung cancer is critical to patient survival. Unfortunately the vast majority of cases are
detected once symptoms arise and the cancer has spread offering patients little hope for cure (average 5-year
survival rate < 15%). The U.S. Preventive Services Task Force recommends individuals at high risk of
developing lung cancer undergo yearly screening with low dose computed tomography (LDCT). Screening is
highly sensitive at detecting lung nodules and has resulted in a reduction in mortality of these patients,
however only 5% of nodules detected are likely to be cancer. Diagnosis of lung cancer must be made on the
microscopic level which is traditionally done by obtaining tissue specimens for subsequent histopathology
examination. Methods for biopsy generally fall under two categories; high-risk surgical and transthoracic
procedures that provide a higher diagnostic yield, and low-risk bronchoscopy based procedures that generally
have a lower yield. Given that the vast majority of nodules detected by LDCT screening are benign it is critical
that the high-risk procedures for diagnosis are avoided. The low diagnostic yields of bronchoscopy based
biopsy procedures can be attributed to insufficiently large, inappropriately located, or non-diagnostic tissue
sampling. Therefore there is a critical need to dramatically increase the diagnostic yield of low-risk bronchial
biopsy approaches. In our laboratory we have developed novel optical coherence tomography (OCT) imaging
approaches to provide high-resolution images of tissue microstructure. We have additionally developed and
disseminated OCT interpretation criteria for the diagnosis lung cancer. In this proposal we aim to further
develop our endobronchial OCT imaging catheters to provide images with superior resolution and contrast with
the goal of microscopically guiding biopsy site selection to increase tumor yield (Aim 2), and to use our
endomicroscopy images and previously developed image interpretation criteria to provide a preliminary
diagnosis of the lesion within the procedure room (Aim 3). The intra-procedural diagnostic endomicroscopy
images could be useful complementary information provided to pathologists in addition to the tiny physical
biopsy specimens for diagnosis, or to enable immediate diagnosis and treatment of small lesions without
requiring a second procedure.

Public health relevance
Project Narrative Public Health Relevance Statement The early diagnosis of lung cancer is critical to patient survival. Unfortunately biopsy procedures that offer higher diagnostic yields are associated with significantly higher risks to the patient, and lower-risk bronchoscopic approaches are hampered by low diagnostic yields. The goal of this application is to develop a powerful optical bronchoscopy tool to increase the diagnostic yield of low risk approaches by 1) guiding biopsy site selection, and 2) by providing in vivo optical diagnoses that will allow for immediate treatment of the target tissue within the single clinical procedure.